Characterization, Evaluation, and Implementation of Innovative TBI Intensive Evaluation and Treatment Programs (IETP)

The Veterans Health Administration, Physical Medicine and Rehabilitation (PM&R) National
Program Office developed five specialty Polytrauma Rehabilitation Centers (PRC) to provide
comprehensive rehabilitation services for persons with traumatic brain injury (TBI). To date
effective dissemination and implementation of extant and emerging findings into clinical care for
individuals with TBI remains limited– specifically those with mild TBI (mTBI), restricting the VA’s
ability to maximize efforts to deliver care across the PRCs as a continuous learning healthcare
system. One program has yielded high visibility and high consumer demand – TBI Intensive
Evaluation and Treatment Program (IETP), an innovative modality for delivering evidence-based
care in a residential, inpatient format. IETP programs provide bundled evidence-based
assessment, treatment, referral, and case management practices in concordance with existing
guidelines for mild TBI and common co-occurring comorbidities. To date, there has been no formal
characterization or evaluation of the IETP residential program modality to understand facilitators
and barriers to spread the unique elements that create higher consumer demand (for the
successful program at one site) across the system of care. The goal of the PM&R National
Program Office is to facilitate the implementation of the high consumer demand IETP at a single
site to all VA PRCs. The short-term goal of this partnered evaluation is to fully characterize the
innovative modality (TBI-IETP), quantify outcomes, and understand the facilitators and barriers to
spread the program across the system of care. The long-term goal is to fully implement the
effective components of the program across the PM&R system of care at all five of the PRCs. This
three-year concurrent mixed-method partnered evaluation initiative will employ a Community
Based Participatory Approach to conduct the following aims: Aim 1: Describe TBI-IETP services
and state of implementation of these services in each of the five PRCs to identify opportunities for
adaptation and scale. In Aim 1, we will use qualitative observations, semi-structured interviews and
focus groups to describe PRC members and DoD representatives’ experiences and suggestions
for implementing TBI-IETP; and patient’s experiences and needs with TBI-IETP. Findings will
identify TBI-IETP core aspects and identify implementation readiness. Aim 2: Characterize the
relationship between patient characteristics, clinical services and outcomes for TBI-IETP patients
with traumatic brain injury across multiple outcome domains, including trajectories of recovery. In
Aim 2 we will use primary data collection from TBI-IETP participants at each site to best
characterize long-term outcomes and patient satisfaction with treatment, and secondary data to
quantitatively characterize patient level and care system level data. Findings will evaluate the
clinical impact of TBI-IETP components. Aim 3: Develop and deliver an implementation playbook
to support TBI-IETP full implementation at sites to promote adoption of effective TBI-IETP
practices across the polytrauma system of care. In Aim 3, we will triangulate Aim 1 and 2 data to
share data findings with partners and develop an TBI-RCM implementation playbook. The
playbook products from evaluation will support TBI-IETP implementation at sites over time.

Public health relevance
The Physical Medicine and Rehabilitation (PM&R) National Program Office is partnering with QUERI to spread an innovative modality for delivering evidence-based care in a residential, inpatient format. The TBI Intensive Evaluation and Treatment Program (IETP) provide bundled evidence-based assessment, treatment, referral, and case management practices in concordance with existing guidelines for mild TBI and common co-occurring comorbidities. The goal of the PM&R National Program Office is to facilitate the implementation of the successful IETP at a single site to all VA Polytrauma Rehabilitation Centers. The objectives of this 3-year, mixed methods partnered evaluation initiative will triangulate data from characterization efforts (Aim 1) and evaluative efforts (Aim 2) to develop an Implementation Playbook (Aim 3) that will promote system- wide implementation.